Immunobiology of the Rheumatic Diseases

PROJECT SUMMARY/ABSTRACT
This application is the competitive renewal of the “Immunobiology of Rheumatic Diseases”
Training Program at Washington University School of Medicine. The program, which was
initiated in 1977 by Dr. John Atkinson, has a strong record of training postdoctoral fellows who
are committed to careers in rheumatic disease research. The goal of the training program is to
develop independent scientist who will ultimately work to improve outcomes of patients suffering
from rheumatic diseases. The current application, which seeks support for five MD, MD/PhD, or
PhD postdoctoral trainees per year, incorporates a number of new programmatic features to
enhance this training mission. The Program accepts trainees from an expanded pool of
outstanding applicants and benefits from close relationships to the Physician Scientist Training
Programs in both Medicine and Pediatrics, the Institute of Clinical and Translational Sciences,
and the Division of Biology and Biomedical Sciences. New to this competitive renewal is the
offering of a clinical/translational research track which complements our basic science research
track. Trainees will benefit from extensive didactic offerings leading to a Master of Science in
Clinical Investigation degree. The centerpiece of either track remains an intense mentored
research experience. Trainees are mentored by a committed primary faculty mentor, in
collaboration with their scholarship oversight committee. The talented group of 35 well-funded
faculty mentors are organized into four thematic areas- Immune Regulation and Host Defense,
Animal Models of Rheumatic Disease, Clinical/Translational Research, and Omics. These
preceptors are a major strength of this grant. The uniquely collaborative environment among
the faculty preceptors and at WUSM provides an ideal setting for the professional development
of the trainees. Hands on workshops, research seminars and programs in the Responsible
Conduct of Research complement the four thematic areas.

Public health relevance
PROJECT NARRATIVE: The Immunobiology of Rheumatic Diseases Training Program has the singular goal of training basic and clinical investigators to be successful and qualified in carrying out research that benefits patients suffering from rheumatic diseases. Through this program, MD, PhD, and MD/PhD postdoctoral trainees are mentored by established investigators who are actively involved in cutting edge immunology and rheumatic disease research.